HIV DISEASE RESEARCH AGENDA

The rapid evaluation of new antiretroviral agents will be markedly changed by the development of accurate virologic markers. We have developed the concept of plasma HIV viremia as a marker for antiretroviral studies. However, cultur methods are slow and virion detection by HIV-RNA PCR methods may afford a more rapid, sensitive and quantitative assessment of antiviral response to therapy. We feel that a systematic evaluation of plasma viremia and HIV RNA virus detection is warranted and are proposing a series of investigations with the following aims: AIM 1, to further develop plasma viremia as a marker of antiretroviral therapy by assessing the relationship between infectivity of cell-free plasma virus and presence of both cell-associated HIV proviral DNA and cell-free HIV RNA; AIM 2, to develop further a direct ex vivo assay that will measure the in vivo response of HIV infection to antiretrovirals an provide a method for targeting subsequent in vivo levels for further phase I study; AIM 3, determine if the blocking of HIV infectivity by immune-based viral neutralization therapies, such as sCD4 and antiretrovirals such as the glycosylation inhibitor deoxynorjirimycin and protease inhibitors, will decrease cell-associated and cell-free infectious titers of HIV and quantity of HIV nucleic acid. We anticipate that these methods will prove to be a particularly useful in vitro guide for he more rapid assessment of antiretrovirals in general; particularly those with either a narrow therapeutic index or poor bioavailability following oral dosing. In conjunction with other quantitative virologic methods such as cell-dilution infectivity assays, HIV-DNA distribution of HIV among the various cell- associated and cell-free reservoirs during antiretroviral therapy, and will thus expedite the overall early phase I and II development of these drugs.